CORE--MORPHOLOGY AND MOLECULAR IMAGING

This Core will be a molecular morphology and image analysis core. This core will integrate with all projects, providing support and expertise for morphologic and histologic phenotypic analysis of the animal and cellular models generated. This core is set up to provide training and supervision in the techniques used to image tissues and cells, as well as intercellular and intracellular interactions. The investigators will have access to core facilities to run their own experiments, assisted if needed by the members of the Core and their technical staff.